Cardiac biomarkers, intensive blood pressure treatment and risk of adverse cardiovascular outcomes in type 2 diabetes, a secondary analysis of the ACCORD BP

Project Summary
Blood pressure (BP) control is an effective preventive intervention to reduce the risk of cardiovascular disease,
especially heart failure (HF). However, among adults with type 2 diabetes (T2D), the effects of intensive BP
control for HF prevention are not well established. There may be high-risk individuals with T2D who are more
likely to derive greater benefits from intensive BP control. The American Diabetes Association recommends
measurement of cardiac biomarkers, specifically N-terminal pro-B-type natriuretic peptide (NT-proBNP) and
high-sensitivity cardiac troponin T (hs-cTnT), to identify and target individuals at high risk for developing HF
with effective therapies as part of a comprehensive HF prevention strategy. In this study, we propose to
evaluate whether a cardiac biomarker-based approach can inform intensive BP control treatment decisions in
high-risk adults with T2D to prevent HF. The study will examine participants enrolled in the ACCORD-BP trial
with available biospecimens to measure cardiac biomarkers. We will measure NT-proBNP and hs-cTnT at
baseline and follow-up years 1, 2, and 4 among ACCORD-BP trial participants who have blood stored in the
NHLBI Biorepository. The prognostic implications of baseline and longitudinal changes in NT-proBNP and hs-
cTnT for HF risk will be examined in a secondary analysis of the ACCORD-BP trial. Additionally, we will
evaluate whether NT-proBNP and hs-cTnT levels modify the treatment effects of intensive BP control. Finally,
we will test the hypothesis that intensive BP control can attenuate the expected rise in NT-proBNP and hs-
cTnT over follow-up. The proposed study will further our understanding of the clinical utility of cardiac
biomarker testing as part of a HF prevention strategy and provide preliminary data for designing a cardiac
biomarker-guided intensive BP control trial in T2D for HF prevention.

Public health relevance
Project Narrative Type 2 diabetes is a growing public health concern associated with increased risk of heart failure. However, there are limited strategies to identify which patients with type 2 diabetes may benefit from preventive therapies such as intensive blood pressure control. We propose to measure N-terminal pro-B-type natriuretic peptide and high-sensitivity cardiac troponin T from blood stored by the NHLBI Biorepository of participants enrolled in the ACCORD-BP trial to evaluate whether a biomarker-based approach can inform intensive blood pressure control treatment decisions among high-risk adults with type 2 diabetes to prevent heart failure.